The causal role of the medial prefrontal cortex in human social cognition

PROJECT SUMMARY
Three decades of research on social neuroscience have identified a set of brain regions supporting human social
cognition; however, critical gaps in our understanding of the causal mechanisms between these regions prevent
the explanation and treatment for disorders affecting social cognition, such as autism. Our long-term goal is to
describe the relations among brain regions and the networks that determine social behavior in health and disease
The overall objective for this application is to sharpen our understanding of the causal role for the medial
prefrontal cortex (MPFC) in the brain network for social cognition. The central hypothesis is that a unique
combination of the lesion method, well-established behavioral assessments, and high-quality neuroimaging data
will provide evidence that MPFC is a causal node in the brain network for social cognition. The rationale for this
project is that identifying MPFC’s role in orchestrating brain regions and producing social behavior is likely to
provide a strong basis for the development of neurobiological models of social cognition in conditions where the
function is impaired (e.g., autism, schizophrenia). Guided by supportive preliminary data, the following three
specific aims will be pursued: In Aim 1, the predictive value of MPFC lesion location on social cognitive profiles
will be determined by using multivariate lesion symptom mapping in Iowa Neurological Patient Registry
participants who will complete a new social task battery extending currently limited social cognitive
characterization. In Aim 2, we will evaluate MPFC function during social behavior with a well-established social
inference task during 7T functional magnetic resonance imaging (fMRI) in individuals with lesions to regions i) in
MPFC, ii) in the social brain network outside of MPFC, iii) outside of the social brain network and iv) healthy
adults (matched for e.g., age, sex, IQ). In Aim 3, MPFC’s role in the social brain network will be validated by
comparing how lesions to MPFC impact a graphical network model derived from densely sampled resting state
7T fMRI data from large neuroimaging datasets and well-matched new collected healthy samples. The research
proposed in this application is innovative, because it combines big data (> 2000 subjects with and without focal
brain lesions) with novel applications of lesion approaches towards understanding the neurobiology of human
social cognition. The proposed research is significant, because it is expected to provide a strong scientific
foundation for the development of neurobiological models of social cognition in conditions where the function is
impaired.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is expected to provide a brain network-based framework for the role of the medial prefrontal cortex (MPFC) in human social behavior by using a novel combination of lesion approaches to behavioral and neuroimaging data. Once such a framework for the causal role of MPFC in social cognition has been developed, there is the potential that a significant advance toward identifying biomarkers for atypical social cognition in psychiatric illness. The proposed research is relevant to the part of the NIMH’s mission pertaining to transforming the understanding of mental illnesses through basic research by defining brain mechanisms underlying complex behaviors.